Dissecting neural mechanisms integrating multiple inputs in C. elegans

Summary
Atypical sensory-based behaviors are a common feature of a number of human conditions, including autism
spectrum disorder, schizophrenia, etc. Despite this, little is known about how the genes associated with these
conditions affect sensory behavior. A complete understanding of this process requires a thorough
characterization of the underlying neural circuitry, along with the ability to measure and perturb the activity of
these circuits. The nematode, Caenorhabditis elegans, provides a unique opportunity to analyze genes, cells,
and circuits regulating complex behaviors, as its nervous system consists of just 302 neurons interconnected via
identified synapses that utilize highly conserved synaptic machinery. The Chalasani, Hart, and Pierce labs have
shown that loss-of-function mutants in C. elegans homologs of the human autism-associated genes (neurexin
(NRX) and neuroligin (NLG)) greatly attenuate aggregation behavior in both wild and lab strains. In addition, the
Chalasani and Hart labs have found that NRX is required in specific chemosensory neurons and intact glutamate
signaling to modify aggregation behavior. They propose to map the synaptic signaling pathways that are modified
by NRX-NLG signaling to regulate aggregation behavior (Aim 1). The Pierce lab has recently found evidence for
natural genetic variation that interacts with NRX and NLG to modify aggregation deficits. They propose to identify
the relevant genes and validate them using QTL mapping, revealing insights into the NRX-, and NLG-genome
interactions critical for animal behavior and intestine physiology (Aim 2). The Chalasani lab has discovered that
NRX, but not NLG loss-of-function mutants have leaky intestines. Next, they obtained intestinal-specific
transcriptomes to identify candidate genes whose expression is selectively altered in NRX mutants. They
propose to use genetic methods to confirm roles for these genes in affecting intestinal integrity. Notably, these
signaling pathways, whose mammalian homologs might be relevant to gastrointestinal issues observed in
individuals with an ASD diagnosis (Aim 3). These studies will reveal the genes, neurons, synapses, and signaling
pathways by which NRX-NLG signaling drives sensory behavior and animal physiology. Importantly, this
proposal brings together three labs with complementary expertise to make rapid progress toward revealing the
mechanisms underlying the complex NRX-NLG phenotypes.

Public health relevance
PROJECT NARRATIVE Atypical sensitivity to sensory stimuli is a hallmark of multiple disorders including autism, schizophrenia, fragile X and others. We propose to use a simple well-defined model with conserved signaling pathways to understand how disease-associated genes like neurexin and neuroligin affect brain function. We aim to use our model to develop new early diagnostic tools and identify new targets for therapeutic intervention in these diseases.